Biosynthetic Development and Diversification of Moroidin Peptides for Cancer Applications

PROJECT SUMMARY
Macrocyclic peptides are effective scaffolds for cancer drug discovery because they can combine the
metabolic stability and target specificity of biologics with oral bioavailability and membrane permeability of
small molecules. The bicyclic octapeptide moroidin is a promising lead structure for anticancer therapy.
Moroidin is characterized by an N-terminal pyroglutamate and two tryptophan side-chain cross-linkages. Due
to low-yield isolation from source-plant material and synthetic challenges toward macrocyclic complexity and
chirality, an optimized biosynthetic route is needed to diversify and produce moroidin analogs in a heterologous
expression system.
Moroidin is a ribosomally synthesized and post-translationally modified peptide derived from autocatalytic
Japanese kerria peptide cyclase KjaBURP, which installs the tryptophan-crosslinks to a leucine and a histidine
side chain in a copper-dependent reaction. KjaBURP encodes four moroidin core peptide motifs attached to
the C-terminal catalytic BURP domain. Based on preliminary work, I hypothesize that the second moroidin ring
can be exploited to generate hundreds of analogs with chemopreventative potential. In Specific Aim 1,
metabolic engineering of the moroidin pathway via heterologous expression of moroidin cyclase constructs
such as KjaBURP in Nicotiana benthamiana will maximize biosynthetic access to natural moroidins and its
analogs. Specific Aim 2 seeks to generate a small library of semi-pure moroidin analogs in transgenic tobacco
by engineered KjaBURP, test their cytotoxic activity against cancer cell lines, and use various high-throughput
scoring methods to propose a mechanism of action for dose-responsive peptides. The proposed research of
moroidin pathway engineering is an approach to generate and biologically screen new plant peptide libraries
for utility in cancer drug discovery.

Public health relevance
PROJECT NARRATIVE The World Health Organization and 2030 United Nations Agenda for Sustainable Development have urged research aimed at reducing cancer mortality rates. Plant peptide natural products with macrocyclizations, such as moroidins, are an important source of anticancer agents, but their synthetic production and diversification has been challenging due to complex macrocyclization chemistry. Metabolic engineering of moroidin biosynthesis in transgenic Nicotiana benthamiana will generate a small library of moroidin analogs for high- content screening and mechanistic elucidation in cancer cell lines.